Creation of Knockout Laboratory Opossums

PROJECT SUMMARY/ABSTRACT
The laboratory opossum is the only marsupial that is available in large numbers for biomedical research. It is
a unique or specialized model for research on many human diseases and developmental processes, as well as
for comparative biology and comparative genomics purposes. The PI maintains the largest breeding and
research colony of this species in the world. The most critical barrier to fulfilling the full research potential of the
laboratory opossum is the lack of success of anyone in the US in establishing gene-editing procedures for this
species. A Japanese group recently overcame the technological impediments to gene editing of this species,
and succeeded in knocking out the tyrosinase (Tyr) gene in a random-bred stock. The implementation and
optimization of their methods at the PI’s laboratory will pave the way for achieving the long-term objective, which
is to establish a national research resource that is capable of efficiently and economically creating gene-edited
opossums required by US investigators to address important biomedical questions that this laboratory animal is
uniquely suited to address.
The specific aims of the parent project are 1) to establish expertise and proof-of-principle in our laboratory by
targeted disruption of Tyr in a fully inbred strain of laboratory opossums, and 2) to conduct targeted disruption of
the phosphatase and tensin homolog gene (Pten) in opossums of the same inbred strain. Knockout opossums
will be created by applying CRISPR-Cas9 technology to opossum embryos collected prior to 34 hours after
copulation, when the egg shell becomes too hard to penetrate. Penetration will be enhanced via the use of a
piezoelectric actuator. Confirmation of knockout genotype will be established by genomic DNA analysis of
progeny weaned from the treated embryos, and from subsequent generations of animals produced from those
progeny.
The specific aim of the supplement is to conduct targeted disruption of the µ gene that encodes the
µ polypeptide of the γµ T cell receptor dimer. All mammals have the αβ and γδ T cell receptors, but only
marsupials have the µ gene and the γµ T cell receptor. Its function is not known. Creating a knockout of the
µ gene will provide new insights into the mechanisms by which T cell receptors contribute to cellular immunity.
This aim will be accomplished using the techniques that are being developed in the parent project.
After the conclusion of the parent grant and the supplement, the animals with the disrupted µ gene will be bred
to produce a stock that will be used for research on function of the γµ T cell receptor and its functional
relationships with the αβ and γδ T cell receptors. Since T cell receptors are critical to the immune response to
pathogens and to immunosurveillance for cancers, opossums lacking the γµ T cell receptor may play an
important role in improving our understanding of mechanisms by which T cell receptors function, and ultimately
in developing new strategies for preventing and treating infectious diseases and cancer.

Public health relevance
The overarching objective of the parent project is to establish in the US, for the first time, the technologies required to genetically engineer laboratory opossums (which are born at the developmental stage of a 6-week human embryo) for the purpose of answering critical biomedical questions that cannot be answered by research with other laboratory animals. The goal of this application for a minority supplement is to produce genetically modified opossums that are lacking a gene that is believed to affect the immune response capability. The key outcome will be to enable future research on the mechanisms of immune response, and on how the response can be strengthened in individuals with limited immune response capacity.